Deracemization of Beta2- and Gamma2-amino acids

PROJECT SUMMARY/ABSTRACT
The pharmaceutical and agrochemical industries rely heavily on the stereoselective preparation of chiral
molecules because opposite enantiomers often demonstrate disparate activities. Though numerous approaches
exist to obtain enantiomerically enriched material, these methods typically require the synthesis of specialized
starting materials/reagents. The catalytic deracemization of racemic material is an attractive alternative, as
racemic synthesis is often straightforward and enantioinduction can be achieved by a catalytic rather than
stoichiometric process. In recent years, photocatalysis has emerged as a strategy for driving systems out of
equilibrium and accomplishing deracemization reactions. However, despite the prevalence of the α-carbonyl
stereocenter in peptidomimetics, natural products, and pharmaceuticals, the catalytic deracemization of this
scaffold has not been achieved in a general sense; this may be in part due to the challenges associated with
generating a reactive intermediate at the acidic α-position under mild conditions, coupled with the lack of
nucleophilic HAA reagents.
This proposal seeks to unlock a new reactivity platform within the field of stereochemical editing and utilize it to
enable deracemization of α-carbonyl stereocenters. Leveraging the Wendlandt group’s expertise in asymmetric
catalysis, we will investigate stereoselective hydrogen atom abstraction (HAA) using chiral amine-borane
catalysts and develop a deracemization protocol for the conversion of racemic starting materials into high-value
enantioenriched products. Prior literature has established proof of concept for kinetic resolution of α-carbonyl
stereocenters with these reagents, albeit with modest selectivity outcomes; however, their extension to
deracemization has not yet been investigated or accomplished. We seek to leverage these chiral amine-boryl
radicals and photoredox catalysis for the development of a novel method for the deracemization of α-carbonyl
stereocenters, with a particular focus on biologically active motifs such as β2- and γ2- amino acids. Ultimately,
we seek to establish amine-boranes as a modern reagent class for selective HAA of acidic C–H bonds and gain
a deeper understanding of the factors affecting enantioselectivity of HAA with amine-boryl radical species. We
will accomplish these goals through synthesis of novel catalysts and evaluation of their reactivity via
spectroscopic studies.
Research will be carried out at MIT, an institution that excels in synthetic chemistry. I will receive training in
asymmetric catalysis from Prof. Alison Wendlandt, a trailblazer in the stereochemical editing field, training in
photophysics from Prof. Schlau-Cohen, an expert in ultrafast spectroscopy, as well as training in organoboron
chemistry through informal interactions with Prof. Robert Gilliard and his research group at MIT. The proposed
research is highly complementary to my doctoral training in the data science-driven study of pharmaceutically
relevant reactions, enabling me to expand my skillset to include asymmetric catalysis, photophysics, and main
group catalysis.

Public health relevance
PROJECT NARRATIVE Deracemization of α-carbonyl stereocenters offers a straightforward method for the preparation of chiral molecules of biological significance, such as β- and γ-amino acid derivatives. Amine-boryl radical species are promising for enantioselective hydrogen atom abstraction (HAA) at α-carbonyl stereocenters, though to date, enantioselectivity remains poor, application to deracemization has not been established, and their structure/reactivity relationship remains poorly understood. We describe a strategy for the photocatalytic deracemization of β- and γ-amino acid derivatives using amine-boryl radicals and elucidation of the principles governing the HAA reactivity of amine-boryl radicals.